Conference on Epigenetics in Development and Disease

DESCRIPTION (provided by applicant): The aim of this meeting is to integrate advances in basic research on the mechanisms of gene control with the remarkable progress made in medicine linking the covalent modifications of DNA and histones with the etiology of human disease. A major goal is to introduce postdocs and graduate students to current research on this topic and to enhance their decision making process by creating the opportunity for them to interact with leaders in epigenetics. 1999 through 2000 saw major discoveries linking human disease to epigenetic gene control. In particular, inheritable changes in gene expression dependent on DNA methylation and changes in histone acetylation, are associated with the most prevalent forms of inherited human mental retardation, Rett syndrome and Fragile X syndrome. Many human cancers develop as a consequence of aberrant methylation and deacetylation of the chromosomal loci of tumor suppressor genes. Epigenetic change is driven by changes in chromatin metabolism as individuals age and is subject to environmental and dietary influence. Defining the human epigenome is a major challenge for the post-genomic era. How is gene activity orchestrated in normal development and what goes awry in human disease? Another aim of this meeting is to bring together leaders in applied research areas with those working on more basic model systems. The free exchange of ideas and atmosphere in the Keystone format should greatly accelerate progress in developing new diagnostic tests and potential therapies.